Molecular mechanisms of motor skill stabilization

PROJECT SUMMARY
Successful motor skill learning is marked by decreased performance variability over time. For
motor skills learned during early developmental time periods, such as walking and talking, performance
remains highly stable and precise throughout life, suggesting that associated motor circuits exist in a
stable state that is tuned to performance. Motor skill stabilization has been studied in terms of changes to
neural population coding, neurophysiology, and synaptic plasticity, yet the molecular mechanisms that
transition motor circuits to a state that supports stable motor performance are unknown. Like
developmental motor skills in humans, the song of the Bengalese finch, an established animal model for
the neural mechanisms supporting skill learning, is learned over the first few months of life, becomes less
variable and plastic over time, and remains highly stable throughout a bird’s life. Birdsong is controlled by
a dedicated neural circuit whose connectivity, neuronal composition, and molecular properties are similar
to those of cortical motor circuits in mammals. The objective of this project is to leverage the
experimental accessibility of the birdsong neural circuit and the highly quantifiable nature of birdsong to
define the molecular mechanisms that regulate the transition from variable to stable motor skill
performance. Recent advances in genomics and single-cell molecular assays have enabled
genome-wide, cell-resolved analyses of how the molecular attributes of the birdsong neural circuit
change during song learning and performance. Our preliminary data indicate that birdsong stabilization is
associated with a suite of transcriptional changes in the birdsong neural circuit. In the proposed research,
we will test the hypothesis that song stabilization is associated with closure of neuronal epigenetic state
in song motor regions using single-nucleus gene expression and chromatin accessibility assays
combined with histone modification profiling (Aim 1). We will then characterize the roles of two candidate
molecular systems, one governed by a transcription factor and the other a neuropeptide pathway, in
regulating the maturation of song circuitry and the stabilization of song (Aims 2 and 3). First, we will
characterize the role of the homeodomain transcription factor SIX2, whose expression is dynamically
regulated during song stabilization, in establishing projection neuron identity in a cortical song motor
region using gene expression manipulations, transcriptomics assays, and sensitive analyses of birdsong
variability (Aim 2). Finally, we will determine the role of the corticotropin releasing hormone (CRH)
neuropeptide system in regulating the developmental balance between song stability and variability (Aim
3). Together, the proposed research will shed light on the molecular mechanisms that regulate motor
stabilization and reveal candidate factors whose dysfunction underlie developmental motor disorders.

Public health relevance
PROJECT NARRATIVE Developmental motor skills, such as learning to walk or speak, first start as highly variable behaviors that then gradually become more consistent as the skill is successfully learned. Deficits in the stabilization of motor control are associated with motor disorders such as developmental dyspraxia, yet the biological basis of this dysfunction is poorly understood. The goal of the proposed research is to understand the molecular mechanisms in a cortical motor circuit that regulate this transition from variable to precise motor skill action.